Faith Communities and African-American Women with T2DM

[unreadable] DESCRIPTION (provided by applicant): African-American women with type 2 diabetes (T2DM) suffer disproportionately from high rates of diabetes- related complications and premature death. To improve outcomes in this population, the CDC recommends partnering with faith communities in the delivery of diabetes health education programs. Yet, little is known about developing and implementing diabetes programs in partnership with faith communities. The proposed study will address this knowledge gap, exploring community values, health beliefs, and community actions in the context of diabetes among African-American faith communities. A minimum of 7 faith communities, each represented by 8-10 members (women with T2DM and their faith leaders), will be sampled. Using a descriptive, longitudinal design, the study will follow the inquiry group method, which integrates traditional focus group interviewing with participatory action research principles. Each faith community will participate in a separate inquiry group process guided by an interview guide addressing faith community values, benefits and barriers to diabetes self-care behavior, community-based actions to address diabetes, and collaborative approaches to culturally sensitive diabetes education. The data sets will be analyzed using content analysis. [unreadable] [unreadable] [unreadable]